Early Language and Literacy Acquisition in Children with Hearing Loss

Administrative Supplements to Existing NIH Grants and Cooperative Agreements (Parent Admin Supp Clinical Trial Optional)
NO CHANGES FROM ORIGINALLY AWARDED APPLICATION
PROJECT SUMMARY/ABSTRACT
The long-term objective of this programmatic line of research is to elucidate the relation of oral language,
phonological processing, and print knowledge and literacy achievement for children with hearing loss who are
developing spoken language. This translational work supports NIDCD’s mission of reducing the burden of
communication disorders such as hearing loss and will result in better methods of identifying preschool children
with hearing loss who are most at-risk for later language and literacy deficits. Children with hearing loss have
wide individual variation in literacy outcomes. The median reading outcome for 18-year-olds with hearing loss is
at only a third grade level, but some researchers report reading levels within the average range. Thus, there is
a critical need to develop methods of identifying which children with hearing loss in the preschool years are most
at-risk for later deficits so high-impact intervention can be initiated as early as possible. For children with normal
hearing, oral language, phonological processing, and print knowledge develop over the course of the preschool
years and are moderate to strong predictors of later literacy achievement. Children with hearing loss exhibit
difficulties in acquisition of each of these areas, with particular difficulty in phonological awareness, conceptual
print knowledge, and complex syntax production. The contributions, however, of each preschool oral language,
phonological processing, and print knowledge skill to later literacy achievement for children with hearing loss are
unknown. The aims of this longitudinal study are to (a) determine the developmental trajectories of spoken and
written language for children with hearing loss across the elementary school years, (b) determine the unique
contributions of preschool oral language, phonological processing, and print knowledge to grade 3 literacy
achievement in children with hearing loss, and (c) consider how lexical-semantic knowledge contributes to areas
of particularly delayed growth in children with hearing loss, and how those delays specifically contribute to literacy
outcomes in elementary school. This study will provide a better understanding about how spoken and written
language develop, as well as how preschool oral language, phonological processing, and print knowledge
contribute to later literacy achievement in children with hearing loss. Such knowledge will have a significant long-
term impact on identification of preschool children with hearing loss who are most at-risk for later spoken
language and literacy deficits, as well as the development of high-impact early intervention.

Public health relevance
Administrative Supplements to Existing NIH Grants and Cooperative Agreements (Parent Admin Supp Clinical Trial Optional) NO CHANGES FROM ORIGINALLY AWARDED APPLICATION PROJECT NARRATIVE Median reading outcomes for individuals with hearing loss plateau at the third-grade level. The proposed research is relevant to public health and NIDCD’s mission to improve the lives of individuals with communication disorders because it contributes to our understanding of how spoken and written language develop, as well as how preschool oral language, phonological processing, and print knowledge are interrelated and contribute to elementary school literacy achievement, in children with hearing loss who use spoken language. This research step is essential in the design of early identification and early intervention methods for children with hearing loss who are most at-risk for later language and literacy deficits.